VASCULAR EFFECTS OF CHELATION IN LEAD EXPOSED WORKERS

Low level lead exposure has been implicated in the pathogenesis of increased blood pressure, particularly in black males. The current study attempts to elucidate the mechanism for lead-associated increases in blood pressure by examining whether reduction in soft tissue lead burden by EDTA chelation will reduce the pressor response to infused norepinephrine.